Understanding the regulatory language of RNA localization

PROJECT SUMMARY
Eukaryotic cells contain within them a myriad of spatially distinct sites that serve a variety of functions.
To facilitate this organization, eukaryotic gene expression is routinely spatially regulated through the trafficking
and sequestration of thousands of different RNA molecules to distinct cellular locations. Misregulation of this
process leads to detrimental phenotypes in a wide range of systems, from developmental defects in Drosophila
to neurological disease in humans.
Despite this importance, our knowledge of the regulation of RNA localization is quite limited. For other
modes of post-transcriptional regulation like splicing, our understanding of how the interactions of RNA binding
proteins (RBPs) and RNA motifs lead to specific outcomes is much more mature. This relies on many years of
work by many groups that have defined the regulatory language of splicing and allows us to make predictive
and combinatorial models about how splicing is regulated across conditions and cellular environments. We lack
such an ability with regards to RNA localization, in large part because we lack the analogous “parts list” that
defines the language of localization regulation.
The overall goal of the Taliaferro lab is to learn this language and be able to build predictive models that
explain how RNAs are trafficked to their intracellular destinations. This includes identification of sequences
within RNAs that govern their transport as well as RNA-binding proteins that bind these sequences and
mediate the process. Historically, these features have been identified for one RNA at a time through a time
consuming and laborious process. Although these studies form the foundation of the RNA localization field, the
amount of effort they require has limited their application to a large number of RNAs. Further, it is often hard to
take findings from these single-transcript experiments and generalize them into larger principles that underlie
rules that govern the transport of thousands of RNAs.
The Taliaferro lab aims to approach this problem from the opposite direction by isolating subcellular
transcriptomes and identifying features shared in common among RNAs localized to a particular destination.
This strategy identifies elements associated with the transport of hundreds of RNAs at once, parallelizing the
one-transcript-at-a-time approaches used in the past. During the course of the proposed experiments, over the
next five years, the Taliaferro lab will use a variety of high-throughput approaches to both discover new
sequence elements that regulate RNA localization as well as deeply characterize previously identified
elements in order to discern how they work. Additionally, we will develop new technologies that will facilitate the
definition of RNA localization mechanisms in organisms and cell types that thus far have been intractable. We
expect that results from these studies will be a positive step toward our goal of understanding and eventually
applying the molecular language of RNA localization regulation.

Public health relevance
PROJECT NARRATIVE The efficient subcellular localization of specific RNAs is a widespread process that is important for the proper functioning of diverse cell types across a wide range of organisms. Despite this, our understanding of the molecular language that underlies the regulation of this process is quite sparse. This proposal uses genome engineering, subcellular fractionation, single molecule imaging, and high-throughput sequencing to dissect the rules that govern how RNAs are distributed within cells with a focus on discovering RNA cis-elements and RNA-binding trans-factors that regulate the process.